Supporting health equity with bias-free pulse oximetry

Project Summary
Pulse oximeters are essential for physicians’ diagnosis and monitoring of respiratory anomalies in patients.
During the COVID-19 pandemic, their importance has grown because pulse-oximeter measurements of
hypoxemia have become the major indication for hospitalizing patients. Clinical studies have shown that
commercially available pulse oximeter measurements (SpO2) systematically overestimate true arterial oxygen
saturation measurements (SaO2) for persons with dark skin pigmentation at low concentrations of O2 in the blood.
This bias results in respiratory compromised persons with dark skin not meeting criteria for hospitalization or
initiation of ventilator support, thereby putting specific populations (Black, Latinx, and Native American) at
disproportionately greater risk for higher mortality or morbidity than those with light skin. No published
explanations exist for this well-documented observation and, indeed, the available literature often contrarily
states that pulse oximeter measurements are not affected by skin pigmentation. Our theoretical analysis and
pilot research, however, demonstrate that the bias is due to present-day devices’ use of red light-emitting diode
light sources, whose broad spectral bandwidth interacts with the spectral absorption of melanin concentration in
skin to systematically shift the devices’ calibration. This shift causes artificially high values of SpO2 at low blood
concentrations of O2 for patients with dark skin. The 3 proposed aims will extend our efforts to date, providing a
scientific foundation for eliminating this bias and to foster development and promotion of simple, inexpensive,
and bias-free pulse oximeters. In Aim 1, we will: (a) determine if there are other spectrally-dependent constituents
in the finger that change with each pulse; (b) determine how light-source bandwidth interacts with melanin,
including whether there are other pulse-dependent changes in spectral transmission through the fingers, and
how sensitive SpO2 measurements are to light source bandwidth; (c) specify the practical peak wavelength and
spectral bandwidth needed for bias-free pulse oximetry; and (d) fabricate an optimized light source that provides
bias-free pulse oximeter measurements for testing in Aim 2. In Aim 2, we will demonstrate that the finger probe
developed in Aim 1d provides bias-free pulse oximeter measurements (SpO2) that do not overestimate true
arterial oxygen saturation measurements (SaO2) for persons with dark skin pigmentation at low blood
concentrations of O2. In Aim 3, which will not employ human subjects as in Aims 1 and 2, we will translate our
findings (i.e., print, in-person, and social media) to physicians, hospitals, and health care facilities commonly
serving underrepresented minority populations. As part of Aim 3, in collaboration with a Stakeholder Board
convened by the Institute for Health Equity Research, we will target the medical and affected communities to
mitigate the impact of current devices through educational outreach and introduce them to bias-free pulse
oximeters once they are available. Finally, we will license the technology to major manufacturers of pulse
oximeters, giving preference to those who supply hospitals and clinics serving disadvantaged populations.

Public health relevance
Project Narrative Pulse oximetry has played a crucial role during the COVID-19 pandemic because measurements of hypoxemia serve as the major indication for hospitalizing patients, but clinical studies have shown that commercially available pulse oximeters can systematically overestimate true arterial oxygen saturation for persons with dark skin pigmentation. This bias has resulted in respiratory compromised persons with dark skin not meeting criteria for hospitalization or initiation of ventilator support, thereby putting specific populations (Black, Latinx, and Native American) at disproportionately greater risk for higher mortality or morbidity compared to those with light skin. In view of our pilot research showing that the bias is due, at least in part, to the devices’ use of polychromatic red light-emitting diode (LED) light sources, we are proposing to present, develop, test, and promote an improved and more-accurate light-based technology for the provision and marketing of simple, inexpensive, and bias-free pulse oximeters.